Role of lactate transporters in pulmonary fibrosis

PROJECT SUMMARY / ABSTRACT
Idiopathic pulmonary fibrosis (IPF) is a fatal disease characterized by excessive deposition of extracellular ma-
trix. Myofibroblasts are the primary effector cells of lung fibrogenesis. Identifying molecular mechanisms medi-
ating myofibroblast differentiation will increase our understanding of IPF pathobiology and identify new targets
for antifibrotic therapies. Metabolic reprogramming is one such molecular mechanism essential, yet the con-
nections between metabolism, myofibroblast differentiation, and pulmonary fibrosis are unknown. Our objective
is to define how a new metabolic approach, lactate transporter (MCT) inhibition, prevents myofibroblast differ-
entiation in vitro and in vivo. Our preliminary data implicate lactate transport in IPF pathobiology by showing
increased expression of lactate transporters MCT1 and MCT4 in IPF lung explants. We show that inhibition of
these transporters decreases bleomycin-induced pulmonary fibrosis and myofibroblast differentiation. Lactate
transporter inhibition promotes cellular respiration and mitochondrial efficiency. Transcription factor enrichment
analyses suggest that MCT inhibitors reverse TGFβ-stimulated expression of pro-fibrotic BRD4 target genes.
Together, these data support our central hypothesis that lactate transport inhibition reprograms fibroblast me-
tabolism to attenuate ROS production and BRD4 activation, thereby preventing myofibroblast differentiation
and pulmonary fibrosis. To test this, we will pursue three specific aims: (1) Determine the metabolic conse-
quences of lactate transport inhibition, (2) Determine how lactate transport inhibition alters myofibroblast gene
transcription, and (3) Identify the cellular therapeutic target of lactate transport inhibitors in vivo. In Aim 1, we
will test that MCT inhibition promotes cellular respiration, decreases mitochondrial membrane potential, and
decreases fibrogenic ROS production using metabolic flux analyses, molecular biosensors, and novel meta-
bolic manipulations. In Aim 2, we will test that decreased BRD4 activity is the novel molecular mechanism link-
ing MCT inhibition and myofibroblast differentiation using a gain- and loss-of-function strategy applied to MCT
and BRD4 activity coupled to ChIP-qPCR analyses of BRD4 target gene engagement and myofibroblast phe-
notypic readouts. In Aim 3, we will test that MCT expression is essential for myofibroblast differentiation and
pulmonary fibrosis in vivo using MCT1 and MCT4 conditional knockout animals combined with imaging mass
spectrometry to interrogate fibroblast metabolism in vivo and scRNAseq to quantify fibroblast differentiation.
The rationale for this work is that defining mechanistic links between metabolism, myofibroblast differentiation,
and pulmonary fibrosis will advance the prospects of metabolic therapies for the treatment of IPF. The pro-
posed research is innovative because it focuses on the essential role of lactate transporters in myofibroblast
differentiation in IPF. The research contributions will be significant because they will establish the mechanistic
basis for the efficacy of lactate transporter inhibitors in pulmonary fibrosis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing a new and alternative strategy to treat idiopathic pulmonary fibrosis by targeting lactate metabolism through the inhibition of lactate transporters. Once the molecular mechanisms mediating the beneficial effects of these drugs have been identi- fied, there is the potential for a significant advance in therapy for patients with the disease. Thus, the proposed research is relevant to the NHLBI mission to enable the translation of basic discoveries into clinical practice for the treatment of heart and lung diseases.